Statistical and high-throughput models of enhancer function and evolution

Project Summary
This diversity supplement will help equip Dr. Janet Buckner, an African American
evolutionary ornithologist at the University of Texas Arlington, with cutting-edge skills in
comparative genomics and genome biology. Dr. Buckner currently leads a vibrant
research program in comparative biology, with an emphasis on phylogenetics, molecular
evolution and documenting and understanding convergent evolution, primarily in
vertebrates. However, she has yet to embrace whole-genome analyses that will allow
her to associate genome variation and phenotypic variation using phylogenetic trees. In
this supplement, we accomplish these goals by expanding current data sets in our
respective labs to allow genome-phenome analysis using convergent evolution in diving
ducks (Anatidae) as a model system. Deep diving in ducks is well known to have evolved
multiple times and provides an excellent setting to link genome variation and phenotypic
variation. Both Dr. Buckner and the PI have been amassing data sets on digitally scanned
morphological variation in multiple skeletal elements in ducks, including the skull, hind-
and forelimb elements, and the sternum. Additionally, the PI has been assembling whole-
genome alignments of ducks as part of Aim 2 of the parent award, because ducks have
multiple high-quality genomes available online and because the group displays
substantial morphological variation whose genetic basis is unknown. We will bring
together whole-genome alignments and both discrete and continuous morphological trait
variation in ducks using our core software, PhyloAcc, which has been extended in multiple
ways as part of the parent grant. Additionally, Dr. Buckner will receive mentoring and
career development strategies to increase her competitiveness in applications for federal
funding and to strengthen her publications to ensure achieving tenure at her home
institution and increasing her scientific impact. Together these new technical skills and
mentoring will allow Dr. Buckner and her laboratory to broaden her approaches in
comparative biology and significantly enhance her competitiveness in the funding arena.

Public health relevance
Project Narrative This diversity supplement will expose the candidate to cutting-edge approaches in comparative genomics, specifically in linking genome variation and phenotypic variation using phylogenetic approaches. The candidate will receive mentoring and career development strategies to increase her competitiveness in applications for federal funding and to strengthen her publications to ensure achieving tenure at her home institution and increasing her scientific impact.